Epigenetic regulation of NKX2-1-negative lung adenocarcinoma cellular identity by FoxA1 and FoxA2

PROJECT ABSTRACT
Lung cancer is the leading cause of cancer mortality in both men and women. Despite advances in screening
methods and personalized therapy, patient prognosis remains dismal with 5-year survival rates varying from 4-
17%. Lung adenocarcinoma (LUAD), the most frequently diagnosed subtype of this disease, exhibits substantial
heterogeneity in its cellular identity or tissue differentiation state. Changes in cellular identity have been shown
to strongly correlate with clinical parameters including patient prognosis, sensitivity to chemotherapy, and
development of drug resistance. Currently, the field lacks a comprehensive understanding of the molecular
networks that regulate lung adenocarcinoma cell identity and govern tumor progression. Identifying
master transcriptional regulators will provide novel insight into the mechanisms of cancer progression and lay
the groundwork for the development of therapeutic strategies specific to tumor differentiation state.
Invasive mucinous adenocarcinoma (IMA) is a subtype of LUAD that undergoes pulmonary to gastric lineage
switching during its natural progression. Using genetically engineered mouse models, we have found that loss
of the pulmonary lineage specifier NKX2-1/TTF1 causes gastric transdifferentiation in LUAD, generating murine
tumors that recapitulate the morphology and gene expression profile of human IMA. This gastric lineage switch
is mediated in part by differential chromatin binding of pioneer factors, FoxA1 and FoxA2 (FoxA1/2), which
relocate throughout the genome from pulmonary loci to regulatory elements of gastric genes. Upon NKX2-1 loss,
these gastric genes also undergo chromatin modifications associated with gene activation including increases
in histone 3 lysine 27 acetylation (H3K27ac). However, it is unknown whether FoxA1/2 are required to
mediate these chromatin alterations at their de novo binding sites and thereby, facilitate tumor lineage
switching. In addition to regulating the pulmonary-to-gastric transdifferentiation, FoxA1/2 also modulate LUAD
identity in response to targeted therapy. Pharmacologic inhibition of the mitogen-activated protein kinase
signaling cascade not only causes tumor regression in NKX2-1-negative LUAD, but also results in a gastric
lineage switch that is dependent upon FoxA1/2 activity. Thus, the objective of this proposal is to determine the
mechanism by which FoxA1/2 modulate the chromatin landscape of NKX2-1-negative LUAD in order to control
cancer identity. The central hypothesis is that FoxA1/2 restructure chromatin accessibility and modify the histone/
DNA methylation landscape in order to control LUAD identity. To test this hypothesis, we will determine whether
FoxA1/2 are required for chromatin modulation following Nkx2-1 deletion in established tumors and define the
precise mechanism by which FoxA1/2 mediate these changes. This proposal is significant because it will provide
a deeper understanding of the molecular networks that regulate LUAD cellular identity and tumor progression,
findings which are essential for the development of subtype-specific interventions.

Public health relevance
PROJECT NARRATIVE In lung adenocarcinoma, the most common cause of cancer mortality worldwide, differentiation state correlates with critical clinical parameters, including patient prognosis, response to therapy, and acquisition of drug resistance. However, the field lacks a comprehensive understanding of the mechanisms by which transcriptional regulators modify tissue differentiation state and impact tumor progression. This proposal will investigate the mechanism by which pioneer factors, FoxA1 and FoxA2 coordinately regulate the epigenetic landscape and cellular identity of NKX2-1-negative lung adenocarcinoma; findings which are necessary for the development of subtype-specific therapeutic interventions.